Exposure to armed conflict, climate shocks, and the nutritional status of women and children

PROJECT SUMMARY
This project will study how exposure to armed conflict affects the nutritional status of women and children in
sub-Saharan Africa. I link nutritional data on 725,619 women and 484,546 children from 35 sub-Saharan
African countries to conflict records during physiologically relevant critical periods. I then measure the effects of
conflict exposures on the weight-for-height of children ages 0-23 months, the height-for-age of children ages
24-59 months, and the body mass index of women ages 15-49 years, while controlling for relevant
demographic characteristics and spatio-temporal confounders. I extend overall estimates of conflict effects by
testing for heterogeneity across social groups and between countries, evaluating whether concurrent climate
shocks amplify the effects of conflict, and empirically examining the role of agricultural, economic, health, and
familial mechanisms. I then examine potential selection effects by measuring conflict and climate effects on
fertility and child mortality. The analyses also include a series of supplementary analyses and robustness
checks, such as analyses of adult male body mass index, tests for non-linearities in conflict and climate effects,
and assessments of data quality. This study provides new cross-national evidence about the nutritional effects
of conflict in Africa, fills evidence gaps about acute malnutrition in conflict settings, and integrates the emerging
literatures on the health effects of conflict and climate. The results will inform debates about nutritional security
in a period of widespread conflict and growing climatic variability.

Public health relevance
PROJECT NARRATIVE High levels of armed conflict across sub-Saharan Africa may have significant consequences for the health and nutrition of affected populations, which may be compounded by climate shocks and other stressors. I use large-scale data on women’s and children’s nutrition, armed conflict, and climatic variability to examine the effects of conflict on nutritional status, evaluate if and how these effects are modified by climate shocks, and assess the role of hypothesized causal mechanisms.